The role of the receptor complex and the cofactors in IGSF10 signaling

Immunoglobulin superfamily member 10 (IGSF10) is a large, secreted protein implicated in multiple biological
and pathological processes: IGSF10 mutations are associated with hereditary delayed puberty. Low IGSF10
expression is linked to more aggressive lung and breast cancers. A frameshift mutation in IGSF10 was found in
a case of a hereditary skeletal disorder, Cleidocranial Dysplasia. IGSF10 A1672T variant was found in combined
pituitary hormone deficiency. However, the mechanism of action of IGSF10 is unknown.
The applicant’s group identified the cell surface receptor for IGSF10 and the downstream signaling pathway
regulated by IGSF10. They also identified a putative co-receptor and a secreted co-factor for IGSF10. This
project is directed towards understanding the roles of the receptor complex and the cofactors in IGSF10
signaling. The successful completion of the project will uncover the molecular mechanisms and the biological
roles of the novel signaling pathway mediated by IGSF10. The knowledge gained from this project will lay the
foundation for understanding the physiological roles of this novel signaling pathway as well as the pathological
conditions associated with the dysregulation of this pathway.

Public health relevance
This project will address the biological roles and the molecular mechanisms of the novel signaling pathway mediated by a secreted protein, IGSF10. The basic science knowledge gained from this project will help the understanding of the roles played by IGSF10 in a variety of biological and pathological processes at the molecular levels and facilitate future therapeutic approaches to pathological conditions associated with IGSF10 dysregulation.